Alcohol: A Modifiable Risk Factor for Ataxia and Decline in MCI

ABSTRACT
The overarching aim of this proposal, which is in response to PA-20-185, asks whether alcohol use
exacerbates the motor and cognitive deficits of Mild Cognitive Impairment (MCI) (cross-sectionally), and
whether drinking accelerates progression of MCI toward dementia (longitudinally). The answers have
implications for harm reduction, especially if "non-hazardous levels" of alcohol consumption prove to be
deleterious to individuals with MCI, in terms of postural stability and risk of falling that can affect activities of
daily living and quality of life. We propose three specific aims:
Specific Aim 1: Test cross-sectional and longitudinal relations between drinking rates and static
balance and dynamic gait in MCI and control men and women.
Hypothesis: Higher rates of alcohol use will be associated with greater instability and slower gait in MCI
compared with lower drinking MCI and controls matched in age, sex, and alcohol consumption variables.
Hypothesis: At follow-up, accelerated cognitive decline in those with MCI will be predicted by slower natural
gait and greater alcohol consumption compared with MCI with faster gait and lower alcohol consumption.
Specific Aim 2: Use causal modeling to test multi-factorial determinants of static and dynamic stability
metrics: alcohol consumption, sex, sensory physiology, cognitive performance, hematological
measures of nutrition, physical and cognitive activities history, and activities of daily living (ADL).
Hypothesis: Cross-sectionally, factors related to greater instability in MCI will be greater alcohol consumption,
poorer sensory testing, and markers of poorer nutrition. In turn, these biomarkers of compromised function will
predict poorer ADLs and quality of life.
Hypothesis: Longitudinal measures will confirm cross-sectional relations and identify metrics that track
standing instability, gait slowing, poorer ADL, and decline toward dementia with greater alcohol consumption.
Specific Aim 3: Identify brain mechanisms of instability factors identified with causal modeling.
Hypothesis: Factors related to greater imbalance and gait slowing identified with causal models will be related
to smaller and compromised cerebello-pontine-motor cortical nodes and circuitry, whereas factors defining
cognitive and mnemonic status will be related to smaller limbic and parietal volumes and diminished integrity of
related circuitry. Both the balance and cognitive relations will be mediated by alcohol consumption rates.
Hypothesis: Longitudinal analysis will reveal that these relations are enduring. Further, greater rates of alcohol
consumption in the testing interim will result in accelerated functional decline in stability, gait speed, and
cognitive status and cerebello-pontine-cortical circuitry.
Exploratory analysis will use hypothesis-free, data-driven, in-house machine/deep learning methods to seek
reliable constellations of factors that predict postural instability, gait impairment, and biomarkers of falling.

Public health relevance
NARRATIVE The aging of America together with escalating age-related cognitive decline and increasing alcohol drinking in older men and women signals an urgency to investigate the role of alcohol use in exacerbating cognitive decline toward dementia and postural instability as risk for falls attendant morbidity and mortality. Outcomes of this research have the potential to confirm alcohol consumption as a modifiable risk factor for dementia and for standing and walking instability, thereby providing justification for implementing balance, cognitive, and alcohol assessment in treatment settings and for creating protective strategies to enhance postural stability in standing and walking.